LEAD DETOXIFICATION TECHNOLOGY

The long term objective of this proposed research is to develop a better encapsulant which not only protects lead-pigmented paint, but also detoxifies the lead. This liquid component is intended to combat lead poisoning, the leading environmental childhood disease and provide a safer workplace for lead abatement workers. This would be the first lead abatement product that actually detoxifies lead in case of ingestion and is a safe water base formula. The proposed liquid may be used in several commercial products such as: 1) coatings which would be applied as an interim step before stripping or repairs to protect workers during removal, 2) washing solutions, 3) encapsulants, 4) treatments of lead waste and 5) fogging solutions. Preliminary testing indicates that this liquid formula detoxifies lead by 50%. Phase I research is needed to improve the detoxification levels of the initial formula, analyze the feasibility of incorporating calcium compounds into a final encapsulant product and confirm preliminary results via independent products. Phase II research is necessary to confirm long term effectiveness, simulate actual extreme environmental conditions and formulate optimal mechanical characteristics to meet proposed ASTM methods for encapsulant products. PROPOSED COMMERCIAL APPLICATION: ACT-LAC has shown the potential to detoxify lead pigmented paint and its water base formula is non- -toxic. The ACT-LAC formula may be incorporated into A) a lead safe barrier B) encapsulant C) post washing solution D) lead waste treatment and E) fogging solutions.